Homeostatic Regulation of PIP2-Calcium Signaling

Abstract
This is an administrative supplement application for funding to upgrade an integrated spinning-disk
confocal and total internal reflection fluorescence (TIRF) microscope system in the PI’s lab. This
microscope system is required for carrying out all live-cell imaging experiments proposed in the parent
project that is focused on defining mechanisms regulating PIP2 homeostasis by Nir2 protein at
endoplasmic reticulum (ER)-plasma membrane (PM) junctions during receptor-induced Ca2+ signaling.
This integrated confocal-TIRF microscope system is uniquely set up for monitoring dynamic changes of
PM PIP2 levels and translocation of proteins to ER-PM junctions in the same cells during receptor
stimulation. Such a system is not available at the Imaging Core Facility of our institute. Recently,
several components of this microscope system that was set up in 2009 are losing functionality at a fast
pace. An upgrade of this integrated microscope system is urgently needed to prevent disruptions of the
parent project due to failure of the system. In addition, this upgrade will enable integration of new
technology into the microscope system to meet our imaging needs for the next five to ten years. The
Physiology Department at UT Southwestern will support this upgrade by providing funds to cover the
balance exceeding the budget, and by providing space for the upgraded microscope system. By
replacing the failing and outdated parts with new state-of-the-art microscope components, this upgrade
will significantly increase the capability and throughput of our integrated confocal-TIRF microscope
system to obtain high-quality quantitative imaging results for years to come. This is an investment that
will greatly facilitate the progress and enhance the impact of the parent project.

Public health relevance
Project Narrative This application for administrative supplemental grant is to request fund for upgrading a unique microscope system in the PI’s lab used for multi-channel, high-resolution, and long time-lapse measurements of dynamic signaling processes in living cells. This upgrade will significantly increase the capability and throughput of the microscope system and greatly enhance the impact of the parent project.